NRSA Training Core

Contact PD/PI: Ford, Daniel Ernest NRSA-Training-001 (618)
The goal of the TL1 Training Programs is to provide an integrated set of training opportunities in clinical/
translational research for pre- and post-doctoral trainees, with rigorous coursework and mentorship personalized
to the interest and needs of each trainee. These programs will build on a strong base of expertise in training in
clinical investigation at Johns Hopkins University (JHU) Schools of Medicine, Nursing, Public Health, and
Engineering; The University of Maryland Baltimore (UMB) Schools of Medicine, Pharmacy, Nursing, Law, Social
Work and Dentistry; and Morgan State University (MSU) Schools of Community Health & Policy and School of
Computer, Mathematical & Natural Sciences. TL1 trainees integrate into an interdisciplinary, highly collaborative
culture interacting with each other and with experienced faculty. We will teach core research competencies,
providing trainees with the necessary skills to conduct clinical and translational research of the highest caliber, and
to excel as teachers, leaders, and role models for the next generation of translational investigators. These TL1
programs build on the success of our current training program that has already successfully trained >100
students, expanding its reach beyond JHU to include trainees from MSU and UMB and a small number of
trainees at the post-doctoral level, and expanding the range of training opportunities across campuses. Our
Specific Aims are: (1) enroll 12 pre-doctoral students/year who will be guided to create and implement a one-year
educational and experiential program with coursework for most primarily in epidemiology/biostatistics (MPH or
MHS) or biomedical engineering (MSE), (2) enroll 4 post-doctoral scholars/year who will pursue a 2-year
program of advanced training primarily the design and early-stage development of innovative health care
solutions (biomedical engineering innovation, design and commercialization) that are responsive to needs of
patients and communities, (3) increase the diversity of trainees by building on our current successes in
recruiting women and those underrepresented in medicine, and (4) perform a continuous evaluation to improve
our program. In addition to the expansive range of didactic training opportunities, the centerpiece of the TL1
research training experience is immersion in a mentored clinical research project. All TL1 Scholars will have
overlap in core programmatic features such as a program advisor who oversees their progress according to
each trainee’s individual development plan, training in the responsible conduct of research, and ICTR resources
such as the biostatistical core, community advisory board, and biweekly translational seminars (including
research in progress, career development, and innovative science series). Our program will be administered by
core faculty with extensive experience leading research training programs; teaching research principles and
methods; recruiting, training, and mentoring underrepresented minority scholars; and leading their own
successful research programs. Our training program will be marked by its inclusiveness and collegiality, and by
our strong commitment to the success of our trainees.